SHAPEIT+Salmon: haplotype phasing and RNA-seq quantification for allele-specific eQTL mapping

PROJECT SUMMARY / ABSTRACT Allele-speciﬁc expression quantitative trait locus (eQTL) mapping has become increasingly popular, since it en- hances the traditional eQTL mapping by providing signiﬁcantly more detailed gene regulatory mechanisms un- derlying the genetic architecture of diseases. Allele-speciﬁc eQTL mapping identiﬁes cis-acting and trans-acting eQTLs that each pinpoint to cis-regulatory elements and trans-acting factors, by leveraging the fact that unlike trans-acting eQTLs, cis-acting eQTLs affect the expression of transcripts from the same haplotype as the variant itself, causing allelic imbalance in expression. However, allele-speciﬁc eQTL mapping requires a reliable long- range phasing of genome sequences and an accurate allele-speciﬁc expression quantiﬁcation from RNA-seq data consistent with the genome phasing. Most existing works have treated allele-speciﬁc expression quantiﬁcation and phasing as independent tasks, even though each can enhance the accuracy of the other. In this proposed research, we will modify and pair up the two widely-used tools, SHAPEIT for genome phasing and Salmon for RNA-seq quantiﬁcation, to obtain an accurate phasing and allele-speciﬁc expression quantiﬁcation consistent with each other for allele-speciﬁc eQTL mapping. The combined tool will inherit or enhance the accuracy and efﬁciency of the two original methods. If phased sequences are known from experimental or trio data, we will replace the EM algorithm of Salmon with an accelerated EM to address the extreme multi-mapped read problem with computational efﬁciency. If phased sequences are not available as in unrelated individuals, we will modify SHAPEIT to jointly phase the variants and allele-speciﬁc read abundances, embedding allele-speciﬁc expression quantiﬁcation within SHAPEIT and using Salmon for obtaining transcript quantiﬁcation and allele-speciﬁc read abundances. As a testbed, we will use genotype and RNA-seq data from a 50 generation intercross, cross be- tween two inbred mouse strains. Because these data are derived from two fully sequenced inbred founders, the correct phase is known. Though we use mice as a testbed, our approach is applicable to data from any diseases, tissues, and organisms, including GTEx data.

Public health relevance
NARRATIVE Our research will provide biomedical researchers and clinicians with efﬁcient computational tools for obtaining phased genotype data and allele-speciﬁc expression quantiﬁcation from RNA-seq data in preparation for allele- speciﬁc eQTL mapping to study the genetic architecture of diseases. Our computational tool will also beneﬁt any biomedical researchers in need of accurate haplotype phases in population genetics studies and accurate allele- speciﬁc expression quantiﬁcation for detecting allelic imbalance in gene expression. Our analysis of LG×SM AIL mouse data will generate a set of candidate cis-acting and trans-acting mutations that provide insights into gene regulation in human psychiatric disorders.